The kynurenine-AHR pathway in biomass production

PROJECT SUMMARY
Increased uptake and synthesis of macromolecules is essential to sustain the demands of hyperproliferative
cancer cells. Therefore, developing approaches to limit biomass production specifically in tumors could have
profound implications for cancer treatment. While seminal studies have shown that the universal oncogene
MYC promotes protein synthesis in cancer cells, there is still a gap in our understanding of how MYC molecularly
controls translation during oncogenic transformation. We found that the transcription factor aryl hydrocarbon
receptor (AHR) and its ligand kynurenine, a byproduct of the amino acid tryptophan, are induced by MYC in
colon cancer cells. Our preliminary results indicate that AHR is necessary for the expression of genes involved
in ribosomal biogenesis and protein synthesis in proliferating cells. Our hypothesis is that AHR senses and
responds to tryptophan-derived kynurenine by translocating into the nucleus and inducing the transcription of
genes that mediate ribosome biogenesis and translation in colon cancer cells. Aim 1 will directly test the role of
AHR in protein synthesis in colon cancer cells, using genetic silencing in isogenic lines of human colonic
epithelial cells and of mouse organoids progressed to colon cancer. Aim 2 will establish the contribution of
kynurenine to AHR-regulated protein synthesis and cell proliferation by examining the requirement for
kynurenine for the expression of AHR target genes, protein synthesis, and growth. We will utilize AHR knockout
cells and animals and a competitive inhibitor that prevents the binding of kynurenine to AHR to define AHR-
specific functions regulated by kynurenine. Aim 3 will directly test the importance of tryptophan-metabolizing
enzymes in generating kynurenine and in regulating proliferation of colonic cells. We will determine the effects
of knocking down or knocking out enzymes in the kynurenine pathway to define their requirement for AHR
activity, protein synthesis, and proliferation of colon cancer cells and organoids. This study has the potential to
define a direct physiological role for the kynurenine-AHR pathway in driving increased biomass production and
cell proliferation in colon cancer. Moreover, this study will broaden the understanding of the role of kynurenine
as an oncometabolite. Our findings could become the basis for the development of novel approaches to limit
kynurenine production and AHR activity as a means to treat MYC-dependent tumors.

Public health relevance
PROJECT NARRATIVE The continuous proliferation of cancer cells demands profound translational and metabolic reprograming. Nevertheless, we still lack a clear picture of the unique adaptations that facilitate aberrant biomass accumulation specifically in cancer cells. This proposal seeks to understand the role of the transcription factor aryl hydrocarbon receptor (AHR) and its ligand kynurenine in protein synthesis and proliferation of colon cancer cells.